P30 Center Core Grant for Vision Research

ABSTRACT
Cellular Imaging Core
A crucial focus of vision research laboratories at the University of Oklahoma Health Sciences Center is
understanding ocular tissue physiology and pathophysiology at the cellular level. Every vision research
laboratory on our campus requires the infrastructure and training necessary to label, image, and quantitatively
analyze tissues at the cellular and subcellular levels. Furthermore, the competitiveness of our researchers
requires that they incorporate new imaging modalities, analytical approaches, and hardware into their research
programs. Training on and access to state-of-the-art cellular imaging modalities is expensive and necessitates
shared core facilities to foster innovative new research approaches and collaborations, to sustain high
productivity, and remain at the forefront of the field. The Cellular Imaging and Morphometric Analysis Core
(CIC) currently supports vision research on 16 NEI-funded R01 grants, providing highly knowledgeable expert
support along with the bright field, epifluorescence, stereomicroscopes and laser scanning confocal
microscopes for image capture at the macro and micro levels. The highly sophisticated software packages
provided by the CIC (Metamorph and Imaris) enable vision researchers to render and analyze images. The
core provides access and high quality training for students, postdoctoral fellows, staff, and principal
investigators on the use of CIC equipment and resources to greatly expand their investigative capabilities,
develop creative new ideas, and promote collaborative interactions.